A ratcheting prosthetic partial finger using advanced rapid manufacturing technology

A Ratcheting Prosthetic Partial Finger Using Advanced Rapid Manufacturing Technology Project Summary / Abstract The goal of the proposed project is to develop and commercialize a purely mechanical, ratcheting prosthetic partial finger – the Point Partial – which 1) has an industry leading strength to weight ratio, 2) can be operated unilaterally, 3) offers anatomical rotation and flexion around the patient’s proximal interphalangeal joint, and 4) can be custom-made for each patient using advanced metal 3D printing technology. The care of upper limb amputees requires a highly individualized approach to medicine. Each patient brings unique needs to the clinic including various levels of amputation, lifestyles, personal experience, and other medical indicators. Prosthetists and occupational therapists work with each patient to provide a personalized medical solution using whatever components and technologies are available on the open market. Very often, the bottleneck in this system is the development of clinically sound prosthetic components that can be readily sourced by the prosthetists to provide an optimal prosthetic limb system. The largest population of upper limb amputees are those missing full or partial fingers. This population outnumbers all other levels of upper limb amputees by a factor of 10. Therefore, we can make a significant clinical impact if a product serves this population effectively. However, current commercial products for partial finger amputees do not satisfy all of the needs of these patients; body-powered fingers are seen as being weak and tiresome to use while cosmetic fingers cannot be used for manual tasks required by many prosthetic users. In this Phase 2 effort, we propose to 1) scale the production of the Point Partial for commercial sale, 2) validate the user needs of the Point Partial with partial finger amputees for regulatory requirements and 3) assess the utility of the Point Partial through a clinical take-home study of partial finger amputees. The mission of Point Designs LLC is to innovate devices and algorithms in the field of upper limb prosthetic design. We develop products that provide prosthetists and patients with solutions to meet the unique needs of each patient in this dynamic and challenging healthcare setting. The Point Partial will provide an effective and durable solution for many upper limb amputees with partial finger loss and ensure their ability to enjoy their work, family, and life to the fullest.

Public health relevance
Project Narrative – Point Designs LLC Point Designs LLC proposes to develop and commercialize a purely mechanical, ratcheting prosthetic partial finger – independent from electronics and batteries, thereby reducing cost, size, and complexity while increasing reliability and durability – that can be custom-made for each patient using advanced metal 3D-printing technology. The amputation of full or partial fingers can cause physical, psychosocial, and economic damage to an individual. Replacement of a partial finger requires an elegant mechanical design that can withstand the severe forces, torques, and environmental conditions of everyday life.